Regulation of Gut Innate Lymphoid Cells by Ahr

Project Summary/Abstract
RORgt+ ILC3s are abundant in the intestinal mucosa and play critical roles in gut tissue homeostasis and host-
microbiome interactions under the steady state, and also contribute to host immunity during infection and
inflammation. As a fundamental element for normal development of the immune system, iron is important for
the proliferation and activation of T cells, and participates in the complex interplays among host, commensals,
and pathogens. Our preliminary data suggest that iron metabolism is important for ILC3 maintenance and
function. Ahr together with other transcription factors regulate the transcription of CD71, a key iron transporter
that is crucial for maintaining a functional ILC3 compartment in the gut. Based on the premise and our
preliminary data, we hypothesize that iron metabolism regulated by the Ahr-CD71 axis is important for
intestinal ILC3 maintenance and function. Specifically, we will investigate 1) the iron impact on ILC3
maintenance and function, 2) the regulation of CD71 expression by Ahr-mediated pathway in ILC3s, and 3) the
functional role of Ahr-mediated CD71 pathway in ILC3s during infection. The study represents an emerging
paradigm of immune metabolism and nutrition immunology in health and disease, Successful completion of
proposed experiments will offer an opportunity to elucidate the Ahr-CD71 axis in ILC3s in the gut under the
steady state and during infection, and shed new light on the profound effect of environmental impact on host
immunity.

Public health relevance
Project Narrative RORgt+ group 3 innate lymphoid cells play an important role in infection/inflammation. The proposed experiments will provide novel insights into the role of iron metabolism in ILC3s, and the Ahr-CD71 axis in regulation of RORgt+ cell maintenance and function under the steady state and during infections. Infectious diseases have been increasingly exacting a substantial toll on health in US, and the knowledge gained in this study will help the development of new therapeutic strategies by exploiting the Ahr-CD71-iron axis in ILC3s to combat infection and control inflammation.